Raise Awareness In Students Early (RAISE) Host and Microbe Program

PROJECT SUMMARY
The overarching goal of the Medical University of South Carolina (MUSC) Raise Awareness In Students
Early (RAISE) Host and Microbe Program is to increase the number of qualified individuals from groups
underrepresented in the biomedical and clinical workforce who pursue a graduate STEM degree and career that
bridges microbiology and immunology. To accomplish this goal, the RAISE Program will provide research
experience and academic enrichment that authentically serve underrepresented students in ways that
achieve retention, equity, access, and life-changing outcomes for students. The program will support nine
students from economically and/or socially disadvantaged backgrounds and underrepresented ethnic and racial
groups. Students will be recruited from the Southeast with priority given to applicants from South Carolina non-
research-intensive higher education institutions including Historically Black Colleges and Universities (HBCUs).
The RAISE program will: 1) recruit diverse undergraduate students who demonstrate ambition and determination
to pursue a graduate-level STEM degree; 2) implement a summer training program that will prepare students for
graduate/professional school admission and a biomedical research career; 3) nurture the professional growth of
students and enhance their integration into the academic culture and community; 4) implement a support
program to assist students during the transition from undergraduate to graduate/professional school, and 5)
conduct a process and outcome evaluation to ensure the program responds to emerging needs and meets the
students’ short term and long term objectives. Dr. Yilmaz, DDS, PhD. and Dr. Westwater, PhD. with their
complementary backgrounds in academic mentoring bring forth an integrated undergraduate program
encompassing basic science, clinical knowledge, and team-based leadership. During the 10-week
summer program students will conduct a biomedical hypothesis-driven project under the guidance of a faculty
mentor whose research program is aligned with the National Institute of Allergy and Infectious Diseases (NIAID)
scientific priorities. Training will include academic skills development, scientific communication, professional
networking, work-life management skills, and responsible conduct of research training. Trainees will gain an
appreciation for the translational relevance of their studies through interprofessional experiences in a clinical
setting. The program will culminate with a formal presentation at the MUSC Summer Undergraduate Research
Symposium, a one-day conference in which students present their research to their peers and mentors. Each
student will be paired via the Big Sister/Brother Program with a graduate student, who will provide professional
and social support while on the MUSC campus. Students’ will continue to receive career advancement support
after graduating from the program through the RAISE Alumni Network. Ultimately, the program will prepare the
next generation of skilled, rigorous, and creative scientists who will improve the Nations capacity to address and
eliminate health disparities related to infectious disease and diseases of the immune system.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT There is a large gap in current biomedical research field to address development and training of individuals from underrepresented minorities who would serve as the next generation pool of qualified scientists studying host and microbe interaction. The MUSC RAISE program seeks to overcome barriers that have prevented or hindered undergraduate students from gaining experiences that would engage and inspire students to continue their professional careers in the field of Microbiology and Immunology. The major goal of the RAISE program is to foster the expansion of a cadre of diverse scientists who will become part of the biomedical workforce dedicated to the development of scientific advances to tackle human diseases and disease processes dynamically associated with host and microbe interplay.